Technology Operations Core

Project Summary/Abstract
The Technology Operations Core (TOC) ensures User's have ready access to biological soft x-ray
tomography, and the NCXT soft x-ray microscope XM-2 functions optimally and as scheduled.
The TOC core is responsible for the day-to-day user operation of the Resource. In particular, the
TOC will maintain and calibrate XM-2. The TOC will also be responsible for maintaining and
upgrading ancillary instruments and software to keep the Resource operating at the `state-of-
the-art.' This core will ensure Users get the best possible soft x-ray tomographic data from their
specimens.